ERICH-GENE

Project Summary/Abstract
Stroke is the third leading cause of death and the leading cause of adult disability in the United States. More
adults are affected by stroke each year than Alzheimer’s disease, multiple sclerosis, amyotrophic lateral sclerosis
or Parkinson’s disease. Intracerebral hemorrhage (ICH) represents the most severe subtype of stroke. An
estimated 40-50% of ICH victims will die and more than 80% of survivors remain disabled. Patients with ICH
share histopathological features with other forms of cerebral small vessel disease (CSVD) caused by
hypertension and cerebral amyloid angiopathy. CSVD is a key component of progressive neurologic decline in
Alzheimer’s disease and vascular dementia, and nearly half of ICH survivors develop dementia within 4 years.
Our investigators have previously collaborated to publish the largest genome wide association study of ICH
with ~1500 cases, which identified novel genetic factors that have since gone on to be replicated in CSVD
phenotypes including white matter hyperintensity and small vessel stroke. With greater sample size, we will
uncover additional risk factors for ICH and through those mechanisms, Alzheimer’s and vascular dementias.
The Ethnic/Racial Variations of Intracerebral Hemorrhage (ERICH) study originally recruited over 3000 cases
of spontaneous hemorrhage with equal power among white, black and Hispanic cases. The study design begins
with the philosophy that both ethnicity-specific and non-specific risk factors for ICH may exist, and numerous
ERICH publications support this. We propose to combine additional ICH cases from around the world to
maximize the power of our study to identify novel genetic variants across ethnicities. We have identified over
21,000 cases that have either completed genotyping or have samples available to assess genetic risk of ICH.
However, the critical first step is to perform careful phenotype harmonization, specifically in location of
hemorrhage which stratifies patients clinically, histopathologically, and genetically. Different studies have used
different location definitions which if not harmonized will limit study power due to case misclassification. We have
previously performed phenotype harmonization across our two centers for both ICH case status and location in
>5,000 cases across 3 NIH-funded studies. We intend to complete harmonization on cases with available data,
and expand harmonization to related imaging CSVD phenotypes and clinical outcomes. Next, we will combine
genomic data to create polygenic risk scores (PRS) to stratify cumulative genetic risk of ICH at the individual
level, which may provide a near-term opportunity to leverage genomic association data to improve clinical care.
Finally, we will maximally share all association results and phentoypes through the Cerebrovascular Disease
Knowledge Portal, a freely-accessible on-line collaborative resource established with NINDS support.
If successful, we will have identified risk factors for ICH, subtypes by location and across CSVD neuroimaging
features, which will be valuable as targets for rational therapeutic development. We will also have built PRS for
ICH risk and outcome, as a tool to stratify individuals by ICH risk and provide prognostic information on outcomes.

Public health relevance
Project Narrative This proposal gathers cases of brain hemorrhage from around the world to identify the genetic factors that either cause or protect people from brain hemorrhage. The larger the sample size, the greater the power of the study and the investigators plan to increase the analysis from the current largest of roughly 1,500 cases to over 20,000 cases of brain hemorrhage. Specific ethnic groups may be particularly susceptible to brain hemorrhage and our study focuses on these important differences by ethnicity.